Maximizing outcomes for preschoolers with developmental language disorder: testing the effects of a sequentially targeted naturalistic intervention

PROJECT SUMMARY
Between 7-10% of children have developmental language disorders (DLD) without other developmental
concerns at kindergarten entry,1,2 which place them at significant risk for poor academic and social outcomes
across the school years and into adulthood.3 Brief naturalistic intervention can significantly increase expressive
vocabulary in toddlers with receptive and expressive language delays,4 but it is not sufficient to reduce the
developmental gaps in vocabulary or syntax.5 No studies to date have examined the potential of sustained
early intervention for maximizing language outcomes. The proposed study will: (a) evaluate the effects of a
sequential language intervention on the vocabulary and grammar of young children at risk for developmental
language disorder (DLD) and (b) examine moderators and mediators of intervention effects. The proposed
hybrid intervention (EMT-SF) provides an empirically-supported intervention, Enhanced Milieu Teaching
(EMT), blended with a theoretically-motivated, sentence-focused (SF) sequence of treatment targets6,7 and
new input modification strategies.8,9 The central hypothesis is that intervention will result in greater vocabulary
and grammar outcomes for children at high risk for DLD in the treatment group. The proposed research is a
stratified randomized clinical trial comparing the effects of the EMT-SF intervention, implemented by parents
and therapists, to a control condition and enrolling 108, 30-month-old children and their parents. Four specific
aims guide the study:
1. Compare differences in vocabulary and grammar outcomes in treatment vs control children at
48 months of age.
2. Determine the extent to which parent language input and parental use of intervention strategies
mediate child language outcomes.
3. Determine the extent to which child-level factors and child progress during intervention predict
language outcomes
4. Determine the extent to which the intervention impacts broader aspects of spoken language and
behavior related to literacy and school readiness (decontextualized language, narrative abilities,
behavior problems) (exploratory).
IMPACT: This study will determine if sustained early intervention can reduce the long-term risks of DLD, will
inform developmental theory, and provide critical information that may transform preschool service delivery
models.

Public health relevance
Project Narrative This Phase Il clinical trial evaluates the efficacy of an 18-month parent-implemented intervention for accelerating language growth and reducing risk for developmental language disorders in young children with language delays. Findings will inform developmental theory and practice.